Experimental Cerebral Hemorrhage: Mechanisms and Therapies

Spontaneous intracerebral hemorrhage (ICH) is a common and often fatal stroke subtype. If the patient
survives the ictus, the resulting hematoma within brain parenchyma triggers a series of events leading to
secondary insults and severe neurological deficits. Although the hematoma in human gradually resolves within
several months, restoration of function is graded and usually incomplete. The neurological deficits in ICH
patients are permanent and disabling.
For the past 20 years, I have been examining the hypothesis that the release of components (e.g.,
hemoglobin, iron and thrombin) from the hematoma contributes to ICH-induced brain injury. Our work on iron
(released from hemoglobin) has led to the current Phase II clinical trial of deferoxamine for ICH
(NCT02175225). This proposal continues to examine that underlying hypothesis. Specifically, it will address: 1)
the mechanisms of early erythrocyte lysis in the hematoma; 2) the role of CD163 in hemoglobin clearance after
ICH; 3) the mechanisms of endogenous hematoma removal; 4) the mechanisms of hydrocephalus
development after intraventricular hemorrhage; and 5) combination therapies for ICH.
The purpose of our project is to determine mechanisms of brain damage after brain hemorrhage and to
develop effective therapies. The long-term goal of our studies is to limit hemorrhagic brain damage in patients.

Public health relevance
After a brain bleeding, hematoma mass and blood components from the clot can cause blood-brain barrier disruption, brain edema formation, brain cell death and neurological deficits. The purposes of this project are to investigate the mechanisms of brain injury after hemorrhage and to develop effective therapies. The long-term goal of our studies is to limit brain damage following brain hemorrhage.